Community Outreach Core

The goal of the Community Outreach Core (COC) is to continue supporting the Florida-California Cancer Research, Education, and Engagement (CaRE2) Health Center by sharing scientific data and results from ongoing projects with our communities, promoting clinical research education, and training community members to be supporters leading dissemination efforts on cancer prevention and early detection, and participating in cancer research as well as ambassadors participating in research advisory committees. Our Community Outreach Core (COC) team has over 20 years of experience working in bicoastal community engagement research, with all populations. We will continue supporting Center investigators conducting prostate, pancreatic, and now, lung cancer research. Building on COC’s prior work, our four (4) aims are to: 1) Create and implement a Community Engagement Academy designed to train, support, and measure the impact of 600 community members in sharing information about cancer, cancer research, and the CaRE2 Center and its projects; 2) Develop and deliver to 5,000 community members evidence-based multimedia educational materials, maximizing the use of technology and media, focusing on pancreatic and lung cancer information, cancer research and clinical trials participation, and biospecimens donation for cancer research; 3) Partner with CaRE2 investigators to host educational activities that increase knowledge and awareness about cancer prevention and research in the CaRE2 Center; and 4) Partner with the CaRE2 Planning and Evaluation Core to evaluate the effects of the COC program and activities.